Administrative Core

PROJECT SUMMARY/ABSTRACT
The United States is facing an opioid and overdose crisis that continues to worsen, with over 100,000
American deaths last year. The COBRE on Opioids and Overdose encourages and supports junior
investigators in pursuing clinical and behavioral research that explores the prevention and treatment of opioid
use disorder, as well as the prevention of overdose. The COBRE is driven by the understanding that effective
public health policy regarding opioids overdose requires data derived from high-quality studies like those
proposed by the COBRE Junior Investigators.
The goal of the Administrative Core is to support the continued successful operation of the COBRE by
providing leadership and administrative support to all Investigators, Cores, and Advisory Committees. This will
include oversight and prompt internal and external communication, project, fiscal and regulatory management
as well as ongoing comprehensive evaluation of the entire COBRE. The Administrative Core supports the
mentorship program and the growth of Research Project Leaders into independent researchers as well as the
Pilot program. The Administrative Core is also responsible for promoting the thematic focus of the COBRE in
all COBRE-related activities, including in the recruitment and support of Lead and Pilot Investigators. The
Administrative Core is led by Dr Rich, supported by Dr Green and the Executive Committee (EC) and Advisory
Committee (AC).